Genetic underpinnings of craniofacial disorders explored with spatial sequencing

Malformations of the oral cavity, which include dental anomalies (hypodontia, hyperdontia), cleft lip and or cleft
plate (orofacial cleft, OFC), and salivary gland anomalies (ectopic or aplasia), are among the most common birth
defects in the US. The design of preventative therapies for these disorders will require a precise understanding
of the transcriptional regulatory networks (TRNs) governing development of the relevant tissues. Studies in
model organisms have been invaluable, for instance revealing that mesenchyme in these structures derives from
neural crest and epithelia in them derives largely from oral ectoderm. However, it is unclear how these TRNs are
deployed over developmental time and within spatial domains of the mouth. Moreover, aspects of these TRNs
are likely to be human specific, for instance those regulating the development of secondary dentition, which does
not occur in rodents. Finally, all of the disorders mentioned above have a genetic basis, in none has all of the
heritable risk been fully explained. Knowledge of the TRNs in human tissue is the surest way to find candidate
genes to harbor such risk. Recent advances in our spatial transcriptomics (sciSpace), and access to donated
human fetal tissue, permit these important questions to be addressed in a precise spatio-temporal manner. Here
we propose, in Aim 1, to conduct sciSpace over the entire human face at four critical developmental timepoints
(7-9, 10-12, 13-15, and 16-18 weeks post conception). We will then focus on the secondary palate and the
genetic underpinnings of OFC. We will use computational algorithms to deduce the membership and regulatory
hierarchy of TRNs regulating differentiation of distinct domains of palate epithelium and palate mesenchyme; top
ranking members of these TRNs are strong candidates to harbor the missing heritability for OFC. In Aim 2, we
will use the results of the first aim to develop protocols for converting induced pluripotent stem cells (iPSC) into
palate epithelium and mesenchymal cells. We will engineer iPSC with 2 coding and 2 non-coding variants
associated with OFC, differentiate the engineered iPSC into palate cell types, and subject the differentiated cells
to single cell RNA-seq. This will reveal the specific cell types, and the step in their development, that is affected
by the variants, illuminating the pathogenic mechanisms of OFC. These experiments will identify strong
candidates for the missing heritability for orofacial cleft, improve functional tests of DNA variants associated with
it, and provide the datasets to similarly analyze other inherited craniofacial disorders.

Public health relevance
Malformations of the oral cavity are among the most common birth defects in the US. Progress in design of therapeutic interventions is delayed by an incomplete understanding of the genetic underpinnings of these disorders and our inability to create models of relevant oral cell types from induced pluripotent stem cells. We propose to use spatial transcriptomics on donated human fetal tissue, to reveal details of gene regulatory networks regulating differentiation of relevant oral cell types, and to design growth factor cocktail paradigms to create these cell types in vitro.